Pesticide Use and Markers of ADRD Neurodegeneration among US Farmers

Abstract
Many pesticides are neurotoxic, and high exposures may have long-term neurodegenerative consequences.
However, empirical evidence on the association between pesticides and Alzheimer’s disease and related
dementias (ADRD) is preliminary and inconsistent. This project will identify links between pesticide exposure
and markers across the ADRD neurodegeneration continuum, from preclinical biomarkers to clinical diagnosis.
The study will be conducted among rural farmers, the group with particularly high pesticide exposure. The central
hypothesis is that high pesticide exposure will increase the risk of ADRD neurodegeneration. This project will
leverage 30 years of environmental health data from the Agricultural Health Study (AHS) with longitudinal
cognitive assessments in an AHS sub-cohort - the Pesticides And Sense of Smell (PASS) Study. The central
hypothesis will be tested by pursuing four specific aims: 1) identify pesticides that are associated with incident
ADRD diagnosis using 30 years of comprehensive AHS cohort-wide Medicare-linkage data; and in the AHS-
PASS sub-cohort, 2) identify the association between pesticide exposures and plasma biomarkers of ADRD; 3)
determine the association of pesticide exposures with olfactory loss, a highly sensitive and easily assessable
marker of early ADRD development, and 4) determine the association between pesticide exposures and
cognitive decline and impairment. The AHS enrolled 52,394 U.S. farmers and is one of the world’s largest and
best-characterized agricultural cohorts, with extensive longitudinal assessments of pesticide exposures over
farmers’ prime working years. The ongoing PASS study further laid a solid foundation for leveraging the rich
AHS environmental health data for ADRD research by establishing a sub-cohort of 2,545 AHS farmers with
cognitive, olfaction, and motor assessments. The proposed research will involve longitudinally following PASS
participants, collecting blood samples, and assessing olfaction, gustation, motor, and cognitive function over four
time points. The study will be limited to PASS participants aged 50-79 at enrollment to target windows of
preclinical and prodromal neurodegeneration when disease prevention is more feasible. The scientific rigor of
this project is ensured by state-of-the-science pesticide exposure assessments in an occupationally exposed
population, longitudinal outcome assessments across the ADRD continuum, carefully planned statistical
analyses, and an experienced multidisciplinary and multi-institutional research team. Innovation and
significance: This project will advance our knowledge of the association between pesticide exposures and ADRD
by leveraging 30 years of extensive data from a well-characterized farming population. The project will bring new
insights into the roles that a class of ubiquitous but poorly studied environmental exposures play in various stages
of ADRD development, critically informing mechanistic research and preventive strategies. This project will also
establish a unique ADRD research resource in rarely studied rural populations.

Public health relevance
Project Narrative/Public Health Relevance The proposed study will generate novel and important knowledge on the potential roles of a ubiquitous but rarely studied category of environmental exposure, pesticides, in the development of Alzheimer’s disease and related dementias. This knowledge will benefit public health by improving our understanding of environmental contributions to Alzheimer’s disease and related dementias and identifying modifiable risk factors.